ACTG 250--PHASE I STUDY--NEVIRAPINE IN HIV I INFECTED PREGNANT WOMEN AND NEONATES

This is a Phase I study designed to determine if one dose of Nevirapipne (NVP) given intrapartum to the HIV infected mother will decrease the risk of perinatal transmission.